Nevada IDeA Networks of Biomedical Research Excellence (INBRE): SARS-CoV-2 Surveillance Study

Abstract
Frequent emergence of new SARS-CoV-2 variants is keeping us on alert and requiring a through
surveillance of circulating variants, to trace and track the introduction of unusual variants with a potential to cause
public health problems. During the past two years, we witnessed the emergence of quite a few variants of
concerns (VOCs), which have the ability to evade immune protection, acquired through vaccination/natural
infection as well as enhanced infectivity and transmissibility. The identification of all VOCs has been possible
through a continuous genomic surveillance and whole genome sequencing (WGS) of SARS-CoV-2. Therefore,
adapting a comprehensive SARS-CoV-2 sequencing approach from a large proportion of positive tested
individuals will help in identifying variants early and managing resources to minimize the spread of SARS-CoC-
2. The major goal of this application is to track the dynamics of variants as well as the evolution of any unusual
variants through sequencing of SARS-CoV-2 positive specimens. We have been monitoring SARS-CoV-2
variants in the state of Nevada with particular focus on variants circulating in the Washoe and surrounding
counties of Northern Nevada. We reported the cases of SARS-CoV-2 reinfection, progression of Delta and
Omicron variants overtime after detecting the first cases of respective variants in NV.
Our sequencing efforts from the last year strongly supports that we have the capacity to successfully
determine the dynamics of SARS-CoV-2 and address these epidemiologic questions: 1) Whether different
variants are prevalent among different racial/ethnic and age groups or responsible for different COVID-19
symptoms manifestations?
2) Determine the number of cases caused by different variants and the dynamics of
their change over, to define the transmissibility in the study population. We are using innovative approaches, of
high throughout platform and analyzing the sequences through an in-house pipeline, to quickly identify any
potential variants of concerns. This pipeline can upload sequences directly onto the GISAID databases for
sequence dissemination. The proposed work is highly significant because it will address important
epidemiological question of SARS-CoV-2 prevalence along with devising strategies to minimize the viral spread.
These questions include, but not limited to i) identifying variants associated with specific race/ethnic, age or
gender groups; ii) variants associated with severe or critical cases of COVID-19; iii) dynamics of SARS-CoV-2
variants changeover during the study time period, and iv) whether vaccinated individuals get infected with any
particular variants of SARS-CoV-2. Overall, this proposal is highly suitable for the Notice of Special Interest
(NOSI): Urgent Competitive Revisions to IDeA and NARCH Programs for SARS-CoV-2 Surveillance Studies
(NOT-GM-22-026).

Public health relevance
PROJECT NARRATIVE Emergence of SARS-CoV-2 variants has caused multiple waves of COVID-19 cases in the Unites States and the world. Tracking the introduction and emergence of any variants of concerns (VOCs) is important in devising strategies for minimizing the spread of this virus. Surveillance of SARS-CoV-2 at the genomic levels will determine their association with COVID-19 cases including, but not limited to, variants causing outbreaks, re- infections and infections among vaccinated individuals.